Endothelial Cytoprotective Signaling by Activated Protein C/Protease-activated Receptor-1

Summary/Abstract
There are currently limited treatment options for improving endothelial dysfunction in vascular diseases such as
sepsis, resulting in high morbidity and mortality. Endothelial dysfunction results in endothelial cell activation,
disruption of endothelial barrier function and sensitivity to apoptosis. The long-term goal of this proposal is to
delineate the pathways by which the endothelium can resist injury and disruption to facilitate the advancement
of new targets for therapeutic development. Activated protein C (APC) is a promising therapeutic and exhibits
multiple beneficial effects including stabilization of endothelial barriers and anti-apoptotic activities. Protease-
activated receptor-1 (PAR1), a G protein-coupled receptor (GPCR), is the central mediator of APC cellular
signaling, which requires caveolin-1 (Cav1) and compartmentalization in caveolae. We discovered that APC-
activated PAR1 signals primarily through b-arrestin-2 (b-arr2) to promote endothelial barrier protection, and not
heterotrimeric G proteins like thrombin (Th)-activated PAR1. The overall objective of this proposal is to develop
a mechanistic understanding of how APC/PAR1 generates b-arr2 transducer bias to promote endothelial
cytoprotection. We hypothesize that distinct GRK5 determinants and co-receptors facilitate APC/PAR1-induced
b-arr2 transducer bias to promote endothelial cytoprotection through pathways enabled by Cav1
phosphorylation. We propose three specific aims. Aim 1: To delineate the mechanisms that enable GRK5 to
distinctly regulate APC- vs. Th-induced biased signaling. GRK5 is required for APC-stimulated signaling and
desensitization of Th-induced signaling. However, the mechanisms that enable distinct GRK5 functions is not
known. We will determine if distinct GRK5 functions are regulated by localization to discrete plasma membrane
microdomains such as caveolae using human cultured endothelial cells, a native system that permits the study
of endogenous PAR1 and GRK5 and HEK293 CRISPR/Cas9 knockout cells. Aim 2: To determine the
mechanisms by which APC vs. thrombin control b-arrestin transducer bias. It is not known how b-arrestin
transducer bias (signaling vs. desensitization) is induced by APC- vs. Th-activated PAR1 nor how APC/PAR1
promotes two distinct b-arr2-mediated cytoprotective signaling pathways: dishevelled2 (Dvl2)-Rac1 controls
endothelial barrier protection whereas sphingosine kinase 1 (SphK1)-Akt regulates anti-apoptotic activities. We
will determine if distinct determinants of b-arrestin and GPCR co-receptors control different b-arr2 binding modes
and functions induced by APC vs. thrombin. Aim 3: To define the mechanisms by which APC/PAR1 regulates
Cav1 function to promote cytoprotection. APC/PAR1 stimulates Cav1 phosphorylation but how this modulates
Cav1 function and is integrated into the cytoprotective pathway is not known and will be determined. The
proposed research is innovative because it will test novel hypotheses to explain how GRK5, b-arr2 and Cav1
drive APC/PAR1 endothelial cytoprotective responses in a physiologically relevant context and will help advance
the status of new targets as a future therapeutics for the treatment of endothelial dysfunction.

Public health relevance
Narrative There are currently limited treatment options for improving endothelial dysfunction in vascular diseases, a leading cause of morbidity and mortality. Activated Protein C (APC) is a promising therapeutic that promotes multiple cytoprotective effects including stabilization of endothelial barriers, anti-inflammatory responses and anti-apoptotic activities. The proposed research is important because it will advance the status of APC by understanding the mechanism by which APC activation of protease-activated receptor-1 promotes endothelial cytoprotection.